Optimizing Access, Appropriateness, and Quality of Minimally Invasive Procedures for Veterans

The last five years have seen a paradigm shift in healthcare: new minimally invasive treatments are
now available that can effectively replace surgery for elderly, comorbid patients. The most striking example is
Transcatheter Aortic Valve Replacement (TAVR), the first major minimally invasive structural heart disease
treatment to be disseminated nationally. TAVR is a life-saving option for the approximately 87,000 Veterans
nationwide who suffer from severe aortic stenosis, and thereby face a 50% mortality rate within two years if
left untreated. Preliminary data suggest that the novel complexities associated with TAVR diffusion significantly
impact vulnerable patient populations. Based on prior data, one key mechanism for these disparities may be
that vulnerable patient populations are less equipped to make informed decisions about treatment.
Driven by the hypothesis that vulnerable Veteran populations experience unequal treatment with
TAVR, but that decision support to routinely assess appropriateness and reduce barriers to care for Veterans
can reduce these differences, the aims of this proposal are to: (1) Identify patient level factors that
influence cardiovascular procedural treatment on the spectrum from minimally invasive (newer: TAVR and
older: PCI) to invasive (older: CABG, SAVR) within the VA, categorizing high and low access groups, with non-
VA data comparison. Multivariate, hierarchical logistic regression will be used to determine the association of
patient level factors, including demographic and VA-specific contextual factors (e.g., percent service
connection, proximity to VA procedure site, use of Veterans Choice or Medicare) with procedural use,
identifying “low” and “high” access profile groups. I hypothesize that older, established cardiovascular
procedures will show fewer inequities in care compared to the newest paradigm of care, TAVR. (2) Identify
decisional needs and barriers to achieving appropriate TAVR treatment from the perspectives of Veterans
(stratified into low and high access groups as defined by Aim 1) and their healthcare providers. I will use an
explanatory mixed methods design to conduct semi-structured interviews with a stratified sample of low and
high access profile Veterans referred for TAVR from multiple states and their providers to inform development
of a pilot intervention in Aim 3. I hypothesize that poor understanding of individualized risks and benefits are a
major limitation to appropriate TAVR referrals, with geographic barriers and difficulty using Veterans Choice
options particularly identified among low access profile Veterans. (3) Build and pilot a novel individualized
decision-making tool and patient facing website to improve both appropriateness and access to care, along
with a strategy for implementation into routine VA care. Using TAVR as a model, I will develop and validate
the feasibility of a prototype physician-facing decision aid for incorporation into routine VA care that predicts
individualized risks and benefits of TAVR, as well as a patient-facing website that addresses barriers to
care, such as mapping proximity and quality of the nearest TAVR sites for geographically remote Veterans who
may require use of Veterans Choice.
Through the successful execution of this work, for the first time, potential inequities in access to
TAVR among vulnerable Veterans will be identified, and insights will be revealed into the gaps in decision
making support for Veterans and their physicians that may contribute to these differences. Additionally, this
work will advance the field by piloting the first evidence-based intervention to systematically improve the
appropriateness of care for Veterans receiving minimally invasive procedures by generating
individualized risk-benefit profiles for treatment, with further online innovative decisional support
resources. This will serve as a model for a host of novel minimally invasive treatments now becoming
available across multiple therapeutic disciplines.

Public health relevance
Degenerative aortic valve disease affects 25% of people over age 65. Once it progresses to severe stenosis, if left untreated it portends a 50% mortality rate within two years. More than 87,000 Veterans nationwide face severe stenosis, many at too high risk for open heart surgery. Recently, a groundbreaking, minimally invasive alternative called Transcatheter Aortic Valve Replacement (TAVR) has led a paradigm change in life-saving treatment options for these patients. Yet, access to the procedure remains limited in the VHA. Unique complexities surrounding decision-making in the VA for this novel type of care may further contribute to widening disparities. Because TAVR is a prototype example of the recent exponential growth in minimally invasive procedures across medical disciplines, it is imperative that we address it as we seek to develop tools to help all Veterans benefit from equitable access to these treatments, while protecting those who may suffer harm from them.